PHASE I DOSE ESCALATION, SAFETY, TOLERABILITY OF TAS 103

This study was initiated in October of 1996 and therefore there are no major findings or accomplishments to date. Four patients have been accrued, no toxicity has been seen.